Diversity Supplement for Rohda Yase

PROJECT SUMMARY/ABSTRACT
The objective of this Diversity Supplement is to support an 18-month postbaccalaureate research experience
for Rohda Yase. Ms. Yase is a bachelor’s degree candidate who will be applying to enter into an MD-PhD
program in the fall of 2026. The goal of the parent grant (R01 AR074417) is to understand genetic risk factors
for osteoporosis to identify new drug targets to reduce this massive health burden. Ms. Yase’s work will
supplement SA1 of the parent grant, which is to identify novel genes regulating bone mass and mineral accrual
at bone mineral density (BMD)-associated loci in a reverse genetic screen. In SubAim1B, we proposed to
generate and characterize germline loss-of-function mutants for six genes. The proposed work for this diversity
supplement research project will add a seventh gene to SubAim1B. This gene is related to, but distinct from, the
genes being tested in the parent grant. The career development plan, which includes access to a network of
scientific, career, and clinical mentors, attendance of national conferences, and preparatory coursework, is
tailored to Ms. Yase’s career goal of obtaining an MD-PhD and becoming a physician-scientist. In regard to the
training environment, the PI has a successful record of mentoring individuals with similar career goals as Ms.
Yase, and has demonstrated his commitment to advancing diversity, equity, and inclusion in the biomedical
sciences through outreach, mentorship, and service. The expected impact of this project is that Ms. Yase will
gain skills, experience, and mentorship that grant her new research independence and increase her
competitiveness for the most competitive MD-PhD programs.

Public health relevance
PROJECT NARRATIVE By 2050, osteoporosis is expected to affect >50% of Americans over the age of 50; further, osteoporotic hip fracture incidence is expected to increase by >200% compared to rates in 1990. Recent studies have identified a large number of loci associated with bone mineral density (BMD), an important clinical marker for osteoporosis diagnosis. This project aims to define causal genes at these loci to understand their biological mechanisms, and in turn, identify new drug targets for osteoporosis therapies.